CANCER CENTER SUPPORT GRANT

The Core Support Grant is in support of the organizational structure of the Cancer Center of Hawaii. The grant supports leadership personnel and key investigators in the Center's five departments of Basic Sciences, Clinical Sciences, Epidemiology, Data Resources and Cancer Control. The grant also supports shared resources which consists of computer facility, animal facility, tumor cell bank and a carcinogen biohazard laboratory. Epidemiological research is being conducted at the Center in the multi-ethnic population of Hawaii. Case control studies on diet and breast cancer, trace metals in prostate, role of vitamin A in lung cancer and the mechanism of action of nitrosoamines in gastric cancer are just a few of the many projects funded at the Center.